Reactive astrogliosis regulates blood-brain barrier permeability.

DESCRIPTION (provided by applicant): In multiple sclerosis (MS), breakdown of the blood-brain barrier (BBB) occurs early in lesion formation and correlates with acute clinical exacerbation. Patients with contrast enhancing plaques are more likely to have irreversible injury, as marked by spectroscopy and T1 hypointensities. BBB disruption leads to edema, and allows CNS entry of inflammatory mediators that exacerbate neuropathology and restrict the capacity for repair. By limiting entrance of pathogenic cells and inflammatory factors, permanent damage can be reduced. New therapies directed at BBB breakdown are needed, as presently only high dose corticosteroids effectively treat exacerbations, and their mechanism of action at the BBB is poorly characterized. Understanding BBB disruption may lead to new therapies to restrict acute exacerbation in MS. The BBB exists at the level of brain microvessel endothelial cells (BMVEC), which use tight junctions to restrict paracellular permeability. Transmembrane proteins contributing to tight junction strands include claudins (CLN) and occludin (OCLN). In BMVEC, CLN-5 plays a key role in determining barrier properties, and CLN5-/- mice display BBB disruption and die perinatally. OCLN regulates properties of the BBB, but is not required for barrier formation. Interestingly, establishment of the BBB is not intrinsic to BMVEC, and depends on astrocytes and pericytes. These cells are also strongly implicated in BBB disruption, but the underlying mechanisms are not well understood. We have identified a novel link between astrocyte reactivity and BBB breakdown. Using microarray analysis of human astrocytes, we have found that cytokines expressed in MS induce genes that cause endothelial plasticity. Upregulated transcripts include the angiogenic factor VEGF-A and its transcriptional regulator, HIF-1a. VEGF-A is a potent inducer of BBB disruption and localizes to reactive astrocytes in MS lesions, but the mechanism underlying its effects on the BBB is unknown. Our studies now reveal that VEGF-A disrupts expression of both CLN-5 and OCLN in BMVEC in vitro, and in the CNS. Downregulation of both proteins accompanies induction of VEGF-A and BBB breakdown in EAE, a widely- used animal model of MS. Our rescue experiments in vitro implicate loss of CLN-5 as a key event in BBB opening. Importantly, we have now generated conditional knockout GfapCre:Vegffl/fl and GfapCre:Hif1afl/fl mice to define the roles of VEGF-A and HIF-1a in BBB breakdown. Our data show that BBB disruption is strikingly restricted in both genotypes. Here, we will test the hypothesis that activation of the HIF-VEGF axis in reactive astrocytes promotes BBB breakdown via disruption of endothelial CLN-5 and OCLN. In Aim#1, we will define the mechanism underlying VEGF-induced permeability of CNS microvascular endothelium. In Aim#2, we will use GfapCre:Vegffl/fl and GfapCre:Hif1afl/fl mice to confirm the roles of HIF-1a and VEGF-A in CLN-5 and OCLN disruption and BBB breakdown in vivo. We will also examine whether rescue of endothelial CLN-5 or OCLN restricts BBB disruption. In Aim#3, using GfapCre:Vegffl/fl and GfapCre:Hif11fl/fl mice we will address the relevance of these findings to disease expression in MOG35-55 EAE. This proposal aims to identify pathways responsible for BBB disruption in MS. The long-term goal of this work is to develop new therapies to restrict lesion formation and limit the severity of acute exacerbation in MS patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: In multiple sclerosis (MS), the transcription factor HIF-1a and its downstream effector VEGF-A have been strongly linked to disruption of the blood-brain barrier (BBB) and subsequent damage to the CNS, but the underlying mechanisms have remained unknown. Tight junctions at the level of microvascular CNS endothelium are critical in maintaining BBB integrity, and recently we found that HIF-1a and VEGF-A induce BBB breakdown via disruption of the tight junction proteins CLN-5 and OCLN. In this proposal, using a conditional knockout approach we will determine the roles of HIF-1a, VEGF-A, CLN-5 and OCLN in BBB disruption, with the goal of identifying novel therapeutic targets to restrict lesion formation in MS. NARRATIVE In multiple sclerosis (MS), the transcription factor HIF-1α and its downstream effector VEGF-A have been strongly linked to disruption of the blood-brain barrier (BBB) and subsequent damage to the CNS, but the underlying mechanisms have remained unknown. Tight junctions at the level of microvascular CNS endothelium are critical in maintaining BBB integrity, and recently we found that HIF-1α and VEGF-A induce BBB breakdown via disruption of the tight junction proteins CLN-5 and OCLN. In this proposal, using a conditional knockout approach we will determine the roles of HIF-1α, VEGF-A, CLN-5 and OCLN in BBB disruption, with the goal of identifying novel therapeutic targets to restrict lesion formation in MS. __SpecificAimsTextDelimiter__ Principal Investigator: John, Gareth R 2. SPECIFIC AIMS In multiple sclerosis (MS), breakdown of the blood-brain barrier (BBB) is an early feature of lesion formation and correlates with acute clinical exacerbation [1]. Patients with contrast enhancing plaques indicative of BBB disruption are more likely to have irreversible CNS injury, as marked by spectroscopy and T1 hypointensities [5]. BBB breakdown leads to edema and allows entry into the CNS of inflammatory mediators, antibodies, and plasma proteins that potentiate inflammation and restrict the capacity for repair [6]. By limiting the egress of pathogenic cells and inflammatory mediators into the CNS, permanent damage to the nervous system can be reduced, as seen clinically and radiographically [2-4]. Newer therapies directed at BBB breakdown are needed, as presently only high dose corticosteroids effectively treat acute exacerbations, and their mechanism of action at the BBB is not well characterized [2]. Better understanding of BBB breakdown may lead to therapies to restrict acute exacerbation and improve recovery. The BBB exists at the level of brain microvessel endothelial cells (BMVEC), which use tight junctions to restrict paracellular permeability [7]. Transmembrane proteins localizing to tight junction strands include claudins (CLN) and occludin (OCLN). In BMVEC, CLN-5 plays a key role in determining barrier properties, and CLN5-/- mice display barrier disruption and die perinatally [8, 9]. OCLN regulates properties of the BBB, but is not required for barrier formation [10- 13]. Interestingly, establishment of the BBB is not intrinsic to BMVEC and depends on astrocytes and pericytes [14] [15]. These cells are also strongly implicated in BBB disruption, but the underlying mechanisms are not well understood [16]. We have identified a novel link between astrocyte reactivity and BBB breakdown [17]. Using microarray analysis of human astrocytes, we found that cytokines implicated in MS lesion formation induce genes that cause endothelial plasticity [17]. Upregulated transcripts included the angiogenic factor VEGF-A [18] and its transcriptional regulator HIF- 1α [19]. VEGF-A strongly induces BBB breakdown [20], and localizes to reactive astrocytes in MS [17], but the mechanism by which it disrupts the BBB is unknown. Importantly, our studies now reveal that VEGF-A abrogates both the endothelial tight junction proteins CLN-5 and OCLN, in BMVEC and in the CNS [21]. Suggesting relevance to MS, disruption of both proteins correlates with VEGF-A induction and BBB breakdown in EAE [21]. Our rescue studies in vitro also implicate loss of CLN-5 as a key event in BBB opening [21]. Importantly, in preparatory studies we have now generated conditional knockout GfapCre:Vegffl/fl and GfapCre:Hif1αfl/fl mice to define the roles of VEGF-A and HIF-1α in BBB breakdown. Our pilot data show that BBB disruption in the inflamed CNS is strikingly restricted in both genotypes. In this proposal, we will test the hypothesis that activation of the HIF-VEGF axis in reactive astrocytes promotes BBB breakdown via disruption of endothelial CLN-5 and OCLN. Three Specific Aims are proposed: 1. Define the mechanism underlying the effects of VEGF-A on BMVEC permeability. We will identify the mechanism underlying the effects of VEGF-A on CLN-5 and OCLN and paracellular permeability in CNS microvascular endothelium. Experiment 1a will examine the roles of VEGF receptors 1 and 2 and the coreceptor NRP-1 in these events in primary rodent and human BMVEC. Experiment 1b will define the contributions of PLCγ signaling and endothelial nitric oxide synthase to these events. This work will use selective receptor agonists, antibody and inhibitor blockade of receptors and signaling pathways, and shRNA for signaling molecules. Permeability will be measured using fluorescent dextrans and transendothelial resistance. Findings will be carried forward to work in vivo in Aim #2. 2. Determine the roles of HIF-VEGF and CLN-5 and OCLN in BBB breakdown in vivo. In Experiment 2a, we will use conditional knockout GfapCre:Vegffl/fl and GfapCre:Hif1αfl/fl mice to define the role of astrocytic VEGF-A and HIF- 1α in disruption of endothelial CLN-5/OCLN and BBB breakdown. We have characterized these mice extensively, and our pilot data indicate that BBB breakdown in inflamed CNS is strikingly restricted in both genotypes. Experiment 2b will use endothelial vectors to examine whether rescue of CLN-5 and/or OCLN restricts VEGF-induced BBB disruption in vivo. Our pilot data confirm the feasibility of this work. In Experiment 2c, with our collaborator Dr. Eric Nestler we will use shRNA vectors to define roles of signaling pathways identified in Aim #1 in VEGF-induced BBB disruption in vivo. 3. Examine the roles of HIF-1α and VEGF-A in BBB disruption and disease expression in EAE. We will determine whether conditional inactivation of VEGF-A and HIF-1α in astrocytes restricts BBB breakdown and diminishes clinical deficit and neuropathology in MOG35-55 EAE, a widely used model of MS. These experiments will use MOG35-55 EAE in GfapCre:Vegffl/fl (Experiment 3a) and GfapCre:Hif1αfl/fl mice (Experiment 3b). We have characterized the phenotype of these mice extensively, and are experienced in the use of MOG35-55 EAE [21, 22]. Data will be compared with findings from mice treated with methylprednisolone, a widely used therapy for MS patients in acute exacerbation. This proposal aims to identify pathways responsible for BBB disruption in MS. The long-term goal of this work is to develop therapeutic avenues to restrict lesion formation and consequent damage to the nervous system in MS, and limit the severity of acute clinical exacerbation and improve clinical recovery. PHS 398/2590 (Rev. 01/10) 2 Continuation Format Page